Recruitment & Retention Core

PROJECT SUMMARY – RECRUITMENT & RETENTION CORE
This proposed P01 program has the goal of creating a locus of research examining the pathways by which
technology and digital media (TDM) exposure and usage impact developmental trajectories and health outcomes
in adolescence. The Recruitment and Retention Core (R&R Core) of this proposal will provide the necessary
support to our shared pool of participants who will contribute across all 3 Projects. The R&R Core will serve as
the common channel through which all support and resources for participants occurs to ensure a successful
recruitment and consistent levels of participant engagement over this longitudinal study. The R&R Core will thus
provide coordination and an organizational backbone for the participant experience in this P01 program. The
R&R Core of this P01 program will focus on four Specific Aims. First, the R&R Core will leverage our Recruitment
Ambassadors and consultant towards recruiting a diverse group of adolescent participants as our shared
participant pool. Rolling recruitment will occur over years 1 and 2 of this P01 program to achieve a shared
participant pool of 400 adolescents. Adolescents ages 13-15 years at enrollment will be recruited across different
settings for a 2-year research study experience. We have worked with our Recruitment Ambassadors to create
an initial list of recruitment opportunities that would be refined and implemented at program inception. Second,
the investigators and staff will complete initial and ongoing regulatory processes including human subjects
protocols. Third, the R&R Core will organize and communicate timelines relevant to each participant’s entry time
point over our two-year rolling recruitment. Each participant will be scheduled for every 6-month data collection
experiences and assigned to a group (Group A: n=150 participants with fMRI, Group B: n=250 participants
without fMRI). And finally, the fourth aim of the R&R Core will be to retain participants for the 2-year study. We
have incorporated the perspectives of Dr. Moreno’s research team’s Youth Advisory Board (YAB) into our
proposed retention plans, which include incentives that incorporate internal and external motivations for serving
as a research participant. We are excited about our dynamic R&R Core team, including Core Lead Dr. Selkie
who brings experience recruiting and retaining early adolescents, and P01 PI Dr. Megan Moreno who brings
experience retaining college students in a 5-year study. Research staff on this Core include Victoria Adkins, who
has worked with Dr. Selkie the past 4 years on a longitudinal study of early adolescents. Our Recruitment
Ambassadors will be valued partners in our efforts on this R&R Core. This P01 program provides the opportunity
for alignment in our research efforts through a shared participant pool that all 3 Projects will draw from, and
synergy by triangulation of participant data across Projects. Thus, this Core will enhance the scientific knowledge,
ideas and outcomes obtained through the interactions of the R&R Core, the Admin Core and the 3 Projects.

Public health relevance
PROJECT NARRATIVE – RECRUITMENT & RETENTION CORE Not applicable. Per the Funding Opportunity Announcement PA-HD-22-009, the Project Narrative is not required for the Project or Core components.